Novel Gene-Edited Rat Model for Development of CAA

Cerebral amyloid angiopathy (CAA) is a common amyloidal form of cerebral small vessel disease that is
characterized by the accumulation of fibrillar amyloid b-protein (Ab) in blood vessels of the brain. CAA is a
common vascular comorbidity in patients with Alzheimer’s disease and related disorders (ADRD) but also can
occur sporadically affecting >50% of individuals >80 years. In addition, several related familial forms of CAA
result from mutations that reside within the Ab peptide sequence of AbPP gene including Dutch-type (E22Q)
and Iowa-type (D23N). Cerebral vascular accumulation of Aβ can result in perivascular neuroinflammation,
cerebral infarction, microbleeds, and in severe cases, intracerebral hemorrhages (ICH). Because of these
vascular impacts, CAA is a significant cause of vascular-mediated cognitive impairment and dementia (VCID).
To investigate the pathogenesis of CAA/VCID and to develop and test targeted therapeutic interventions for
this condition appropriate experimental animal models are needed.
To date, studies on CAA have largely centered around the use of transgenic rodents. However, transgenic
models of CAA and ADRDs come with several significant shortcomings including reliance on artificial over-
expression of the transgene, prone to insertional effects on the host genome and susceptible to loss of
transgene expression and genetic drift in subsequent generations. Another major shortcoming of transgenic
lines is that pathology that develops typically is from a ‘sole source’ of expression, typically from neurons, due
to the promoters that drive transgene expression. However, a ‘sole source’ of neuronal Ab is unlikely how the
CAA develops in humans. Since the complexity of the cellular origins of Ab in CAA are not captured in ‘sole
source’ transgenic models they fail to reveal the true pathogenesis of this disorder. This glaring shortcoming
has prompted the quest to generate yet a better experimental animal model for CAA to more fully capture the
pathogenesis of this condition and its role in VCID.
The overall goal of this exploratory proposal is to extensively characterize a novel gene-edited rat model for
small vessel CAA. This will provide a state-of-the-art animal model to the field of CAA and ADRD to more fully
understand how this pathological condition accurately evolves and leads to cerebral vascular pathology, white
matter damage, and VCID. The aim of this proposal is to describe a superior model for the study of small
vessel CAA and provide to the research community a more realistic and physiologically relevant platform to
investigate pathogenic mechanisms and to be able to effectively interrogate new potential biomarkers and
therapeutic interventions for CAA.

Public health relevance
Cerebral amyloid angiopathy (CAA) is a common cerebral small vessel disease of the elderly, an important driver of vascular cognitive impairment and dementia (VCID) and present in Alzheimer’s disease and related disorders (ADRD). Currently, preclinical animal models to study CAA are largely restricted to transgenic rodents. The purpose of this project is to develop and characterize a new state-of-the-art ‘gene-edited’ rat model for the CAA to more accurately investigate the pathogenesis of this condition.